Sieve analysis of breakthrough influenza infections to identify viral and immunological markers of vaccine failure

To support studies to identify viral and immunological markers of influenza vaccine failure.